Adaptation of the Reflexiones Electronic Screening and Brief Intervention for U.S. MSM Seeking HIV Testing.

The overall goal of this administrative supplement is to adapt Reflexiones, our electronic screening and brief
intervention (e-SBI) program to reduce substance use and sexual risk behavior among men who have sex with
men (MSM) in Argentina, for MSM in the U.S. MSM are disproportionally affected by HIV and substance abuse
in the U.S., Europe, and Latin America. However, as in the general population, identifying and engaging MSM
with problematic substance use (PSU) into treatment is a significant challenge, which results in the great majority
of MSM with PSU never receiving treatment. The Substance Abuse and Mental Health Services Administration
(SAMHSA) recommends Screening (S), Brief Intervention (BI), and Referral to Treatment (RT; SBIRT) as an
early intervention for non-treatment-seeking individuals with risky alcohol and drug use, as well as the timely
referral to more intensive substance abuse treatment for those with substance use disorders. To address this
need, we developed Reflexiones, an e-SBI aimed at reducing substance use and HIV sexual risk behavior among
MSM seeking HIV testing at Nexo Asociacion Civil, our community partners in Buenos Aires, Argentina. Our
formative work and pilot (N=46) of Reflexiones has been highly encouraging. On an acceptability assessment
based on the Theoretical Framework of Acceptability 100% of participants agreed the intervention was
acceptable (23% “agreed” and 77% “totally agreed”) and, in qualitative interviews, participants noted how the
intervention helped them reflect on their substance use and sexual risk behavior, topics they did not discuss with
others. All participants felt the intervention was non-judgmental and respectful of individuals who use substances,
which they felt was critical given the “taboo” behaviors discussed. While Reflexiones was designed for MSM in
Buenos Aires, the need for interventions to reduce PSU and sexual risk behavior among MSM in the U.S. is
equally great. As such, the overall goal of this administrative supplement is to adapt and pilot Reflexiones for
MSM in U.S. who are seeking HIV testing at CAN Community Health, our community collaborators in Florida, a
state with seven EHE high-risk counties. While Reflexiones benefits from having been designed for MSM, it must
undergo a formal adaptation process to address issues that have not been relevant in Argentina (e.g., racial and
ethnic representation and language) and its acceptability assessed among the demographically diverse MSM
that typically seek HIV testing in community testing sites in the U.S. To this end, we have partnered with CAN
Community Health to assess its acceptability among intended users and its feasibility during HIV testing visits.
The Specific Aims of this administrative supplement are to 1) Adapt Reflexiones to MSM in the U.S. (renamed
as Reflections); 2) Conduct a pilot study (N=40) to assess the feasibility and acceptability of Reflections among
a diverse sample of MSM coming to a community agency in the U.S. for HIV testing; and 3) Identify barriers and
facilitators to implementing Reflections at CAN.

Public health relevance
This study begins to address a critical need for interventions that reduce both problem substance use (PSU) and HIV risk behavior among MSM. Given that many MSM seek HIV testing in LGBT community agencies, interventions delivered at these agencies in the context of HIV testing have the potential to reach large numbers of MSM, help them reflect on their use of drugs and alcohol, and help link those with PSU to substance abuse treatment. If proven efficacious in a future RCT, implementation of these intervention in such agencies will help address a key contributor to HIV risk behavior and infection as well as reduce drug and alcohol use among MSM, who are disproportionately affected by HIV and substance use.